Assessing a Clinically-meaningful Opioid Withdrawal Phenotype

The US is in the midst of an opioid epidemic with rates of opioid-related morbidity and mortality so high they
are decrementing average US life expectancy. The current need in the US for OUD treatment far exceeds the
number of available treatment slots and treatment access is further complicated by the fact that not all patients
respond in a similar way to our current OUD pharmacotherapies. We are experts in the measurement and
evaluation of opioid withdrawal symptoms, the evaluation of novel medications for OUD treatment, and the
assessment of individual differences in response to opioid medications. We recently conducted an analysis of
a larger RCT that suggested patients could be classified into HIGH and LOW withdrawal phenotypes that were
associated with the participant’s clinical response to OUD treatment medications in the subsequent RCT. This
R01 will follow up on promising preliminary data we have published that suggests there are clinically-
meaningful human opioid withdrawal phenotypes. We propose to conduct a rigorous, highly controlled human
laboratory + spontaneous withdrawal study to verify and investigate these phenotypes. These data will
advance opportunities for phenotype-driven opioid withdrawal management. We will enroll equal numbers of
men and women who have OUD into a residential study. Participants will be stabilized onto an opioid agonist
for a brief period, during which they will complete two naloxone challenges with a placebo or the OUD
medication lofexidine, before beginning a clinical lofexidine-assisted taper and subsequent transition to the
relapse prevention medication naltrexone. Primary aim 1 will identify opioid withdrawal phenotypes. We
hypothesize that participants will separate into two latent classes that will be consistent with expressing a
HIGH or LOW opioid withdrawal phenotype. Primary aim 2 will determine the degree to which naloxone
challenge phenotype is associated with withdrawal during the subsequent clinical taper. We
hypothesize that phenotype class during the naloxone challenge will be significantly associated with SOWS
AUC values during the taper. Secondary Aim 1 will identify behavioral and physiological correlates of
opioid withdrawal severity. We hypothesize that participants who experience varying levels of opioid
withdrawal will show differences in behavioral (Subaim 1) or physiological (Subaim 2) correlates. Secondary
Aim 2 will determine role of sex in withdrawal expression. We hypothesize that men and women will have
different withdrawal severity (Aim 1), that withdrawal from the naloxone challenge session will correspond with
withdrawal during the clinical taper in men and women (Aim 2), and that men and women will have different
behavioral and physiological correlates with opioid withdrawal severity (Secondary Aim 1). Replicating our
previous results by confirming presence of an opioid withdrawal phenotype will help advance personalized
medicine approach to OUD, and understanding factors contributing to withdrawal severity (independent of
phenotype) in men and women will expand opportunities for new medication development more broadly.

Public health relevance
NARRATIVE Persons who withdraw from opioids have different experiences, but little is known about the magnitude of these differences or what might predict different responses across individuals. This study will combine a laboratory session with a clinical treatment trial to learn more about these differences. We will also examine differences between men and women, with a goal of helping providers better match patients to different opioid use disorder treatment medications.